Proof of concept investigation to detect exposure of patients to Cytomegalovirus (CMV) and Herpes Simplex Virus-2 (HSV-2)

To develop a tool to detect anti-CMV and anti-HSV-2 antibodies in human serum to determine and monitor viral status in patients.